CULTURE OF CONTINUOUS LEARNING PROJECT: A BREAKTHROUGH SERIES COLLABORATIVE FOR IMPROVING CHILD CARE AND HEAD START QUALITY

The purpose of this project is to leverage implementation science to close the gap between knowledge and practice in early childhood programs. ACF is interested in understanding how child care and Head Start programs can improve the quality of services received by young children, and also how such quality improvement can be institutionalized to create a culture of ongoing quality improvement at the program level. The project will design and assess the feasibility of implementation of a specific approach to continuous quality improvement - the Breakthrough Series Collaborative - to promote the uptake and success of evidence-based practices in both child care and Head Start settings. OPRE has contracted Child Trends, with a subcontract to the University of Massachusetts-Boston, to conduct the project.